Interrogating the Structural Basis of Nuclear Receptor Activation on Chromatin

PROJECT SUMMARY
Nuclear receptors (NRs) are ligand-gated transcription factors that control important biological processes
including reproduction, development, metabolism, and immunity. NRs are the target of ~16% of drugs used in
the clinic for applications that include birth control, inflammatory disease, and metabolic disorders. NRs are
thought to function by altering the dynamics of chromatin to alter expression levels of genes through the
recruitment of coregulators, chromatin remodelers, and ultimately through the activation of transcriptional
machinery. However, the dynamic nature of NRs and NR complexes has made it challenging to study the
molecular mechanisms by which full length proteins and protein assemblies regulate gene expression using
traditional structural biology techniques. Despite the central role that NRs play in gene expression activation, our
mechanistic understanding of how they regulate target gene programs at the molecular level of chromatin is
largely unknown. This is attributed, in part, to the dearth of structural biology data for full-length receptors and
the near complete absence of biochemical, biophysical, or structural data on NRs in their functionally relevant
chromatin context. Building on established foundations in sponsor’s home laboratory, combined with the
applicant’s prior expertise in biochemical and biophysical methods and an intimate understanding of the NR field,
this project seeks to determine how a model NR named RORγT assembles with coregulatory proteins SRC3
and p300 to alter chromatin dynamics and post-translational modification status of chromatin, a hallmark of NR
target gene activation. The proposed research program has two major goals: (1) to determine how RORγT and
coregulatory protein complexes engage with nucleosomes, and (2) to determine how RORγT and coregulator
protein complexes modify histones and alter nucleosome dynamics. This will be accomplished using a
combination of traditional biochemistry, and state-of-the-art technologies including cryogenic electron
microscopy (cryo-EM) and structural proteomics. By studying how these protein complexes assemble and act
on nucleosomes, we will gain new insight into how RORγT, and more broadly the NR superfamilty, modulates
nucleosome dynamics, modification status, and, ultimately, function in gene regulation. The implications of this
work will help us understand how an important drug target functions and will pave the way for future research
investigating an important class of drug targets.

Public health relevance
PROJECT NARRATIVE Hormones control important biological processes through proteins called nuclear receptors, which are targetted by ~16% of drugs used in the clinic. This proposal takes aim at making never seen observations of a model nuclear receptor named RORγT interacting with and manipulates chromatin. By incorporating novel biological contexts and using interdisciplinary structural biology techniques to study RORγT structure, function, and regulation, this work has the potential to open novel areas of investigation in NR biology, has broad implications to human health and physiology, and may also facilitate the development of chemical modulators with more efficacy and fewer side effects.